Understanding the influence of bone-metastatic prostate cancer and mesenchymal stromal cells on γδ T cells, in the bone microenvironment.

While immunotherapies have made strides in the treatment of other cancers, castrate resistant prostate cancer (CRPC) remains largely unresponsive, underscoring the need for novel approaches. One such approach relies on the administration of autologous T cells genetically modified to express a chimeric antigen receptor (CAR) that recognize specific tumor-associated antigens. Prostate Stem Cell Antigen (PSCA) is widely expressed in prostate cancer and we have previously developed a CAR targeting PSCA that has potent in vivo efficacy. To target bone metastatic CRPC (mCRPC), we propose to manipulate a specific subset of T cells, called ?? that can be driven to the skeleton via systemic treatment with bisphosphonates such as zoledronate (ZOL) that is clinically used to limit cancer-induced bone disease in men with bone mCRPC. Importantly, ZOL treatment induces accumulation of phosphoantigens in tumor cells, which are detected by ?? T cells. Our preliminary findings show that ZOL can enhance ?? T-cells' homing to bone where they can prevent cancer growth via CAR and via endogenous T-cell receptor (TCR) recognition. ?? CAR-T treatment, in presence or absence of ZOL, can mitigate cancer-induced bone deterioration. Moreover, we found that soluble factors secreted by bone marrow derived mesenchymal stromal cells (MSC) can increase the cytotoxic potential of ?? CART cells. Finally, we found that the choice of CAR structural and costimulatory moieties affects the phenotype and fuction ?? and ?? T cells differentially, requiring the design of CARs optimized for ?? T cells. Based on these preliminary findings we hypothesize that the homing and cytotoxic activity of ?? CAR-T cells for the treatment of bone metastatic CRPC can be greatly enhanced through genetic, pharmacological, and microenvironmental approaches. We will test our hypothesis by; 1) Defining the optimum ?? CAR-T design that will significantly enhance CRPC cytotoxicity. We will test the biological implications of choosing alternative CAR transmembrane and costimulatory domains, with a specific focus on their ability to modulate the expression of cytokine receptors. We will also dissect the specific signaling pathways that can govern ?? CAR- T cell persistence. Finally, we will identify the molecular signaling pathways triggered by CARs with different costimulatory domains. 2) Determining if ZOL can drive ?? CAR-T recruitment and anti-bone mCRPC activity in vivo. We will use xenograft and PDX models of bone mCRPC to characterize the bioavailability and therapeutic efficacy of ?? CAR-T + ZOL; and an immunocompetent model to map sites of phosphoantigen accumulation. 3) Dissecting the reciprocal effects of ?? CAR-T on the bone mCRPC microenvironment. We will analyze the impact of ?? CAR-T + ZOL treatment on the structure and physiology of the bone, and the effects of MSC on the performance of ?? CAR-T cells in vivo. Based on the anticipated results, characterizing the specific properties of the bone/tumor microenvironment will reveal novel insights thereby providing a strong rationale for the translation of immunotherapies tailored to eliminate currently incurable bone mCRPC.

Public health relevance
NARRATIVE Advanced prostate cancer remains an incurable disease that often colonizes the skeleton, causing bone destruction and pain. Drugs used to mitigate bone destruction can induce changes in bone metastatic prostate cancer cells that, in turn, attract and activate specific immune cells (γδ T cells). Based on this observation, we propose to study 1) how prostate cancer cells and bone microenvironmental cells namely, mesenchymal stromal cells (MSCs), affect the activity of γδ T cells; 2) how γδ T cells can be manipulated to make them more effective cancer killers by introducing cancer-specific chimeric antigen receptors; and 3) how γδ T cells modify the bone microenvironment response; with the long-term goal of developing novel and more effective immunotherapies for prostate cancer.